CORE C TECHNICAL SUPPORT FACILITY

INTRODUCTION: We are pleased that reviewers found this core to have a positive overall impact on our Program. At the University of Oregon, general IT support for technical units, such as the Institute of Neuroscience, is provided within the unit. Unlike the Program Project Grant, other grants are charged for services. We don't itemize costs for design and fabrication of electronic instrumentation for our Program during the upcoming grant period because, based on our experience, this service is often performed based on unanticipated needs for improving operations within the Zebrafish Facility or one of the other Core units, such as the Microimaging Core, or modifying or building new instrumentation for experiments in the Component Projects.